The Importance of the Neighborhood Environment in Determining Health and Well-being among Persons with Dementia and their Caregivers

PROJECT SUMMARY
The rapid increase in the population with Alzheimer’s disease and related dementias (ADRD) in the United States
constitutes a looming public health crisis. Dementia is a syndrome of progressive cognitive impairment and a
leading cause of disability, loss of independence, institutionalization, and death in older adults. ADRD affect
more than 5 million U.S. adults over age 65, but also impact an estimated 16 million family and friends who, as
primary caregivers, are at increased risk of poor physical and mental health and social isolation. The prevalence
of dementia is expected to increase as the population ages, and there is currently no known treatment that can
cure or substantially slow its progression. A top public health priority, therefore, is to determine how to improve
the lives of persons living with dementia (PWD) in order reduce the impact of dementia on PWD and their
caregivers. Features of the neighborhood social, physical, built, and service environment may provide necessary
support to PWD and their caregivers, or, alternatively, exacerbate the adverse impacts of dementia. The
proposed study will determine how neighborhood-based supportive factors (e.g., meal delivery, home health
care, amenities, walkability) and stressors (e.g., lack of safety, disorder, noise, traffic) affect health and well-
being among PWD and their caregivers. We leverage data from two large, nationally representative, and
longitudinal surveys that have collected information on thousands of PWD and their caregivers and provide
information on their place of residence: the Health and Retirement Study (HRS) and the National Health and
Aging Trends Study (NHATS). We will first create a national, longitudinal database of neighborhood
characteristics that, as indicated by theory and research, reflect opportunities for physical activity, social
engagement, and mental stimulation, supportive services and resources, and psychosocial stressors. Using this
new data resource, which will be made available to the research community, we will estimate the impact of
neighborhood-level factors on multiple dimensions of health and well-being (e.g., frailty, social engagement,
institutionalization) for both PWD and their caregivers. We will further determine if health and well-being vary
across groups defined by race/ethnicity, socioeconomic status, living alone, and residence in urban/rural areas
and assess the role of the neighborhood in generating this inequality. To our knowledge, this will be the first
empirical study to examine, in a national context, how neighborhoods can engender quality of life in PWD and
their caregivers. The proposed study is timely because an increasing number of cities and communities are
engaged in efforts to become more dementia-friendly. This project will identify aspects of neighborhoods and
communities that support living well with dementia and inform policies and programs to reduce the costs and
burden of dementia on individuals, families, and communities.

Public health relevance
PROJECT NARRATIVE Neighborhoods may play an important role in determining quality of life among persons with dementia (PWD) and their caregivers. The objective of this project is to identify neighborhood-based resources and stressors that affect health and well-being among PWD and their caregivers. The knowledge generated from this project will have significant relevance for public health efforts, including the National Plan to Address Alzheimer’s Disease, to identify modifiable aspects of the environment that can improve the lives of PWD and their caregivers.